Understanding Depression risk in Multiracial Americans: A Social Safety Approach

PROJECT SUMMARY/ABSTRACT
Multiracial adults have the highest prevalence of major depression compared to those who select any
single racial category. Despite this disparity, very few studies have attempted to identify unique risks factors
facing this population, and those that have exhibit theoretical and methodological limitations. The overarching
goal of this proposal is to initiate a research program focusing on the reduction and elimination of Multiracial
mental health disparities. As a first step towards this goal, the proposed research investigates a novel
hypothesis to explain elevated rates of major depressive episodes (MDE) in Multiracial adults based on the
generalized unsafety theory of stress: lower levels of racial identity affirmation. In addition, it identifies
inconsistent categorization of Multiracial identity as a critical barrier undermining progress in the field,
examines the effects of this inconsistency, and moves towards a solution for future research. Thus, I propose
the following three aims that will facilitate the development of future research and interventions to reduce MDE
risk in Multiracial Americans. Aim 1 is to test the hypothesis that lower racial identity affirmation partially
explains elevated rates of MDE in Multiracial compared to six monoracial adult groups, above and beyond
other proposed explanations, using mediation analyses and sophisticated epidemiological methods to adjust
for potential confounding. Aim 2 is to test whether the association between racial identity affirmation and MDE
varies across Multiracial categorization schemes. Aim 2a is to inform future categorization decisions by testing
which Multiracial categorization scheme has the best statistical fit to seven potential MDE disparities
mechanisms: racial identity affirmation, racial discrimination, unmet treatment needs, chronic illness, adverse
childhood experiences, other traumatic events, and major life events. Findings from this research will advance
the National Institute of Mental Health’s research priority of reducing and eliminating mental health disparities.
In addition, this mentored dissertation will support the doctoral training and future independent research career
of an emerging Black and Biracial mental health scholar.

Public health relevance
PROJECT NARRATIVE This dissertation proposal, focused on depression in Multiracial Americans, addresses critical gaps in understanding and eliminating a mental health disparity that is largely overlooked by national reduction and elimination initiatives. The proposed research aims to uncover novel insights into the determinants of major depressive episode disparities and inform categorization practices that capture the diversity of Multiracial identity. These contributions have the potential to impact future research and inform targeted interventions mitigating depression risk among Multiracial Americans.